RASA3 is a Candidate Gene in the Pathogenesis of Pulmonary Arterial Hypertension

PROJECT SUMMARY
Pulmonary arterial hypertension (PAH) is a rare disease with poor long-term survival and no targeted therapies
available. Prior studies have established that pulmonary artery endothelial cell (PAEC) injury and dysfunction,
including abnormal proliferation, angiogenesis and apoptosis resistance, plays a critical role in the pathogenesis
of disease. My long-term goal is to identify new molecules that may become therapeutic targets to treat and
improve the lives of patients with PAH. RASA3, a GTPase activating protein, is a negative regulator of Rap1 and
R-Ras, GTPases that regulate angiogenesis, endothelial cell adhesion and turnover, processes highly relevant
to PAH. Previous in vitro studies have shown that RASA3 leads to dysregulation in pathways and processes
highly relevant to pulmonary hypertension. I have found that RASA3 expression is decreased in four large
cohorts of individuals with pulmonary hypertension (PH), and correlates with increased mortality in a cohort of
individuals with sickle cell disease-associated PH. I have identified a single nucleotide polymorphism (SNP)
within the RASA3 gene, rs9525228, that correlates with increased PH severity within four PH cohorts and is
located at a predicted estrogen receptor-α and glucocorticoid binding site. We have also developed a conditional
endothelial cell RASA3 knockout mouse for in vivo studies. The specific objective of the proposed research is
to investigate the role of RASA3 in maintaining PAEC health in vitro and in vivo within the context of pulmonary
vascular disease. I hypothesize that RASA3 is a critical regulator of homeostatic responses in PAEC. This
hypothesis will be tested by investigating the following Specific Aims:
AIM 1. Identify how RASA3-mediated regulation of BMPR2 impacts pulmonary vascular dysfunction in
PAEC. My working hypothesis is that loss of RASA3 leads to dysregulated PAEC homeostasis through
hyperactivation of Rap1 signaling altering cytoskeletal dynamics and resulting in BMPR2 downregulation.
AIM 2. Determine the effects of RASA3 SNP rs9525228 on a PH-relevant phenotype in PAEC. My working
hypothesis is that rs9525228 leads to decreased RASA3 expression.
AIM 3. Determine the endothelial-specific role of RASA3 expression in the development of experimental
pulmonary hypertension. My working hypothesis is that RASA3 mediates pulmonary vascular health at a
proliferative, angiogenic and cell survival level.
Upon completion of the proposed studies, I anticipate that my findings will delineate how loss of RASA3
expression leads to PAEC dysfunction and pulmonary vascular remodeling and establish RASA3 as a
therapeutic target in PAH.

Public health relevance
PROJECT NARRATIVE Pulmonary arterial hypertension is a progressive disease that continues to have a high mortality rate. These studies will evaluate how loss of RASA3, a GTPase activating protein, may predispose individuals to the development of pulmonary arterial hypertension. This work may identify RASA3 as a novel target for therapeutic intervention to improve the quality as well as length of life of patients with pulmonary arterial hypertension.